Training Program in Patient-Oriented Research in Cardiovascular Endocrinology

Title: Training Program in Patient-Oriented Research in Cardiovascular Endocrinology
Abstract
For some time, keen observers of the academic scene have been sounding alarm over an impending manpower crisis in patient-oriented research reflected in steadily declining numbers of clinical investigators since 2000, potentially jeopardizing a highly successful national enterprise of clinical medicine and drug discovery. In spite of these concerns, the number of T32 programs in patient-oriented research (~3% of funded T32 grants) has dwindled and today, few programs are aimed at patient-oriented research in cardiometabolic disorders. This new Training Program in Patient-Oriented Research in Cardiovascular Endocrinology aims to bridge this gap by providing comprehensive, curriculum- and mentor-based training in all aspects of patient-oriented research. The program is founded upon 4 pillars: 1) 16 dedicated NIH-funded primary mentors committed to individualized mentoring; 2) motivated trainees committed to lifelong careers as academic investigators in patient-oriented research; 3) 3 NIH-funded early career investigators committed to developing careers as research mentors; and 4) 6 scientists with expertise in the relevant content areas who will serve as content experts within the trainee's mentoring team. The program's implementation is led by two co-directors (Adler and Bhasin), and 2 committees: Operations Committee (responsible for program administration/ direction, trainee selection, and program evaluation); Career Development / Mentoring Committee (CDMC, responsible for trainee mentoring and career development). The program includes: 1) a didactic curriculum-based learning; 2) research training in setting of mentored research project/s; and 3) an individualized career development plan. Each trainee develops an Individual Development Plan with the guidance of their Mentoring Team, which includes primary mentor, co- mentor, content expert, and CDMC advisor. The curriculum-based learning includes training in ethics in research, genetics and epigenetics, biostatistics and statistical genetics, endocrinology, nutrition and obesity, and cardiovascular endocrinology. Trainees are encouraged to create a trainee-specific curriculum utilizing courses at Mass General Brigham and affiliated academic medical centers. All trainees are required to complete coursework in patient-oriented translational research, biostatistics, Omics technologies, and a specific course in cardiovascular endocrinology. The Program includes structured evaluations of trainees, mentors and the program. Trainee selection is based on recommendation letters, previous training, research interests, commitment to patient-oriented research, and a personal interview. The program's strengths include 2 experienced program co-directors and outstanding mentors with NIH funding, a stellar publication record, and success in training mentees who have advanced to successful academic careers and NIH funding; outstanding institutional infrastructure to support research and training, and a large pool of qualified candidates at Brigham and Women’s Hospital and affiliated academic medical centers.

Public health relevance
The primary mission of this new Training Program is to train post-doctoral fellows in all aspects of patient-oriented research with a particular focus on the role of genetics, epigenetics, and endocrinology in the pathophysiology of cardiometabolic diseases. To accomplish this mission, the Program has recruited 16 outstanding primary mentors, each with a stellar record of NIH funding and excellence in mentorship evidenced by the high rates of retention of their trainees in academic research careers and by the success of their trainees in securing independent K series and/ or R series grants. The program, founded upon three core components - 1) a didactic learning core; 2) a mentored research project component; and 3) an individualized career development plan - is supported by an outstanding institutional research and education infrastructure and culture to accomplish its mission of nurturing the next generation of highly skilled academic investigators with expertise in patient-oriented research.